AUGS/DUKE UrogynCREST program

PROJECT SUMMARY
Health Services Research (HSR) and predictive analytics are rapidly growing fields and will
have enormous implications for women’s health research in pelvic floor disorders (PFDs). The
AUGS/DUKE Urogynecology Clinical Research Educational Scientist Training
(UrogynCREST) program will prepare participants to recognize the critical role that data play in
delivering high quality health care. It brings together expertise in health service and women’s
health research, medical informatics and prediction modeling. This program will target
Urogynecology Faculty at the Assistant Professor level who seek successful careers in health
services research (HSR) and analytics. Participants will obtain skills through a combination of
didactic and interactive coursework; hands-on manipulation of data through extraction, cleaning,
and analysis; and project-based one on one mentoring. The UrogynCREST program will be an
interactive, hands-on educational program with centralized activities organized and delivered by
distance through a popular on-line learning platform called Sakai, with educational software
designed to support teaching, research and collaboration. A diverse faculty with expertise in
data sciences teaches courses and the advanced methodology required to perform HSR. Yearly
in-person meetings at the annual American Urogynecologic Society meeting enhance
networking and the development of partnerships between participants from various institutions,
as well as, interactions with the mentors and other HSR in the field. The program’s strategy
allows national leaders with particular skills in the field to provide their knowledge to the
participants and help mentor them through development of a relevant research question and
identification of an appropriate and existing database(s) to address the question. With the
guidance of a dedicated statistician and analyst programmer, participants will learn and perform
the necessary computer programming needed to extract, clean and analyze these data.
Participants whose projects involve the development of prediction models in the form of scores,
nomograms or other tools will learn how to build and validate such tools in the existing project.
Each participant’s project will culminate in the completion of a submitted manuscript to a peer-
reviewed journal or study proposal and publicly available tools when relevant. Overall, the
program will shape future scientific leaders in Urogynecology by encouraging the development
of clinical-scientists and provide the skills and resources for invigorating data discovery and
tools for investigations in HSR specifically addressing (PFDs).

Public health relevance
PROJECT NARRATIVE: The AUGS/DUKE UrogynCREST program will prepare participants to recognize the critical role that data play in delivering high quality health care for pelvic floor disorders. It will add structure to the health data science education for Assistant Professor Level Faculty in Urogynecology by bringing together expertise in health service and women’s health research, medical informatics, and prediction modeling. Overall, the program will shape future scientific leaders in Urogynecology by encouraging the development of clinical-scientists and provide the skills and mentorship for invigorating data discovery and tools for investigations in health service research specifically addressing pelvic floor disorders.